Genomic Diversity and the Architectures of Adaptation and Incompatibility

Project Summary: Genomic Diversity and the Architectures of Adaptation and Incompatibility
This research program addresses fundamental yet unresolved questions at the interface between genetic
variation and evolutionary processes. In particular, it focuses on three interconnected research themes: (1)
The Genetic Complexity of Adaptive Trait Evolution, (2) The Genetic Basis of Early Stage Reproductive
Isolation, and (3) The Determinants of Genomic Diversity and Adaptive Potential. It fuses ambitious but
cost-effective Drosophila experiments with novel approaches to the analysis of large genomic data sets.
D. melanogaster offers critical advantages for this work. The global expansion of this species enables the
study of adaptive trait differences, and partial reproductive isolation, between populations that diverged in the
last ~10,000 years. Due to this recent time-scale, adaptive differences may be detected from genetic variation.
The experimental efficiency of Drosophila allows the study of large lab populations across many generations.
Its compact genome allows economical sequencing. Once relevant genes are found, functional confirmation
and study are aided by a well-annotated genome and a wealth of genetic resources and transgenic tools.
This research will bolster understanding of The Genetic Complexity of Adaptive Trait Evolution. Initial
findings have suggested a portrait of adaptation that often begins with standing genetic variation, includes
variants with larger effect sizes, and features variable genetic architectures among individuals. Proposed work
will solidify and extend these inferences in multiple respects, including by launching scaled-up mapping studies
for a wider range of adaptive traits, and pursuing previous hints of epistasis involving adaptive variants.
Proposed work will also open up a promising new system for studying The Genetic Basis of Early Stage
Reproductive Isolation. African and European D. melanogaster show evidence of incompatibilities impacting
viability and reproduction, but these have received no genetic study. This research will deploy a combination
of incompatibility mapping and population genomics to identify specific incompatibility genes for further study,
and it will advance understanding of the genetic architecture of the earliest stages of reproductive isolation.
Finally, this research will clarify The Determinants of Genomic Diversity and Adaptive Potential. This
work will feature experimental and computational studies on the relative roles of neutral and adaptive genetic
diversity in future adaptation, and the most relevant ways to quantify each. It will also investigate the relative
importance of different types of natural selection in shaping genomic diversity, including by probing the utility of
genetic differentiation between populations to separate the signals of positive and negative selection.
Collectively, this research is highly consequential for basic evolutionary genetics. It also holds strong
medical relevance in terms of the relevance of local adaptation and epistasis for the genetic basis of human
disease and infertility, and for understanding the evolutionary dynamics of insect disease vectors.

Public health relevance
Narrative This research addresses the genetic underpinnings of adaptive trait evolution and reproductive isolation, and the determinants of genomic diversity. Understanding of the genetic architecture of human disease will benefit from this work’s emphases on detecting local adaptation (which is relevant to immune performance and the risk of diabetes and heart disease) and on interactions among genetic variants (which may contribute to the variable penetrance of many diseases). This research will benefit the study of insect disease vector evolution, and its focus on genetic incompatibilities may inform the causes of miscarriage and couple infertility and the disease risk of Neanderthal genetic variants.